Targeting mechanisms of chromatin plasticity to improve the efficacy of epigenetic solid tumor therapy

PROJECT SUMMARY
Aberrant DNA methylation is a hallmark of nearly all human cancers, driving oncogenesis through abnormal
gene expression. DNA methyltransferase (DNMT) inhibitors hold promise for reversing these abnormal DNA
methylation patterns and act as “priming agents” to enhance immunotherapy in hematological cancers. However,
DNMT inhibitors as single-agent therapies have yielded limited clinical benefit in solid tumors due to insufficient
DNA demethylation and poorly understood resistance mechanisms. The overarching goal of my F99 training
phase is to potentiate the efficacy of DNMT inhibitors for treating solid tumors. Preliminary studies from my
dissertation research have demonstrated that DNMT inhibitor treatment elevates UHRF1-dependent histone H3
lysine 18 ubiquitination (H3K18ub), which stimulates the SUV39H1/H2 methyltransferase activity to establish
transcriptionally repressive histone H3 lysine 9 tri-methylation (H3K9me3) at tumor suppressor gene (TSG)
promoters in colon cancer cells. Disrupting this H3K18ub-directed SUV39H1 activity through loss-of-function
mutations in SUV39H1 ubiquitin interaction motif (UIM) enhanced the DNMT inhibitor-mediated TSG
reactivations, innate immune response gene upregulations, and anti-proliferation effect in colon cancer cells. I
hypothesize that this H3K18ub-H3K9me3 crosstalk is a targetable mechanism that limits DNMT inhibitor
efficacy in solid tumors. In Aim 1 (F99 Phase), I will determine the effects of combined SUV39H1 UIM disruption
and DNMT inhibition on anti-tumor efficacy and immunotherapy responses using syngeneic colon cancer models.
I will also utilize machine learning-based protein design tools to develop SUV39H1 UIM protein/peptide
antagonists that might become lead compounds for potential therapeutic development. In Aim 2 (K00 Phase), I
will extend these chromatin plasticity insights to improve Chimeric Antigen Receptor (CAR) T cell therapy in solid
tumors, leveraging epigenetic modulation to enhance T cell persistence and reduce exhaustion. DNMT3A
depletion has been shown to enhance CAR T cell memory and resistance to exhaustion, while it is unclear
whether compensatory chromatin modifications in DNMT3A-depleted T cells may limit their therapeutic efficacy
in solid tumors. Using a CRISPR screen targeting epigenetic regulators in DNMT3A-depleted CAR T cells, I will
identify key factors that synergize with DNMT3A to strengthen CAR T cell function. I will validate top candidates
for their effects on T cell persistence, memory formation, and antitumor activity in vitro, and I will assess their
potential to sustain durable antitumor responses in vivo. Overall, this project aims to overcome key barriers to
DNMT inhibitor and CAR T cell therapies in solid tumors by identifying novel epigenetic vulnerabilities. By
bridging fundamental epigenetic research with translational cancer therapy, this project will advance therapeutic
strategies for solid tumors and support my development into an independent translational research scientist.

Public health relevance
PROJECT NARRATIVE DNA methyltransferase (DNMT) inhibitors offer promise for reversing the abnormal DNA methylation patterns in cancer and for enhancing cancer immunotherapy, yet their efficacy as single agents in solid tumors remains limited. In the F99 Phase of this proposal, I will target compensatory chromatin plasticity induced by DNMT inhibitor therapy - specifically the crosstalk between UHRF1-dependent H3K18ub and SUV39H1/H2-mediated H3K9me3 - to sensitize colon cancer to both DNMT inhibitor and immune checkpoint therapies. In the K00 phase, I will build on these insights to develop chromatin-targeted approaches that enhance Chimeric Antigen Receptor (CAR) T cell persistence and function in solid tumors, advancing strategies for more effective solid tumor immunotherapy.